Administrative Core

The objectives of the Administrative Core of the proposed Penn Roybal Center are to provide infrastructure
and governance in support of behavioral economics and health research at the University of Pennsylvania and
among affiliated faculty at other universities. There are tremendous opportunities to apply insights from
behavioral economics to health behavior change and delivery science, but significant challenges remain. Chief
among these are the challenges of bringing promising interventions to scale. There are numerous places along
the NIH Stage Model of Behavior Change where the path to scaling can be disrupted, from the generation of
mechanistically well motivated ideas that are shown to be feasible and acceptable in Stage 1 studies to proof
of efficacy in research or real-world settings (Stages 2 and 3), proof of effectiveness (Stage 4), and
dissemination and implementation (Stage 5).
A goal of our Roybal Center is to reduce `voltage drops' along this pathway by embedding user-center design,
allowing for self-service customization to increase both initial efficacy and the ability to engage broader
populations for effectiveness studies; incorporating use of scalable platforms in testing to support potential
translation of research into dissemination and implementation; and by leveraging dynamic adaptation to
increase efficacy and effectiveness. In all of this we plan to work closely with testing and implementation
partners who have wide reach, collectively with access to more than 100 million Americans including diverse
populations.
The Specific Aims of the Administrative Core of our Roybal Center are to:
1.) Provide central administrative support to plan, coordinate, and manage the Center's activities;
2.) Manage the External Advisory Committee that oversees the scientific direction of the Center;
3.) Oversee identification, review, development, and monitoring of pilot projects using the NIH Stage Model;
4.) Encourage and facilitate the development of networks among researchers;
5.) Build strategic collaborations with private and public sector entities to support testing of promising ideas

Public health relevance
The goal of our proposed Roybal Center is to speed up the pace and increase the impact of scientific discoveries about how to change health behaviors to prevent premature aging. To do this, we focus on three innovative strategies: design thinking to incorporate the experiences of older adults; online platforms that help us conduct large-scale studies easily; and dynamic adaptation, which allows us quickly learn how different interventions work for different populations. With these strategies, we will design and conduct studies ranging from small pilots to ensure our interventions can work up to larger-scale studies with companies and health care organizations that show how interventions do work in real-world settings.